Understanding Uncertainty and Improving Parameterization of In-Silico Cardiac Electrophysiology Models

7. Project Summary
Atypical atrial flutter ablation outcomes are poor, with high recurrence rates following ablation procedures.
Patient-specific computational models have recently shown promise as a tool for pre-ablation planning, with
the ability to locate all possible reentrant circuits before a procedure. However, such models suffer from a lack
of parameter optimization and high computational costs. The goal of this project is to apply state-of-the-art
computational methods to improve the parameterization of patient-specific models of atypical atrial flutter. Aim
1 will investigate the effect changing input parameters has on the flutter circuits observed. By systematically
varying these parameters, we will establish a quantitative relationship between model inputs and outputs. This
will help us quantify the uncertainty in the models and identify the most critical parameters that influence the
accuracy of the predictions. Aim 2 will look to increase the accuracy of scar detection from LGE-MRI using
deep learning. Accurate detection of scar tissue from late gadolinium enhancement magnetic resonance
imaging (LGE-MRI) is crucial for creating precise models. We will develop and test an overcomplete
convolutional neural network (CNN) to improve scar segmentation, addressing challenges posed by image
quality and scan variations. Aim 3 strives to personalize the electrophysiology parameters of the model. By
tuning electrophysiology parameters to match patient-specific data, we will compare the accuracy of
personalized versus generalized models in predicting clinically observed circuits. This personalization is
expected to significantly enhance the predictive power of the models, making them more useful for clinical
decision-making. Success in this project will improve the personalization of patient-specific atypical atrial flutter
models, allowing for more accurate prediction and further clinical utilization. This project will also provide me
with the technical expertise and scientific training required to be an independent research scientist in the field
of cardiac electrophysiology and computing.

Public health relevance
8. Project Narrative Atypical atrial flutter is one of the most common atrial arrhythmias to occur following catheter ablation for atrial fibrillation. Computational models have shown promise in guiding repeat catheter ablations for atypical atrial flutter, as they can identify all possible circuits given a patient-specific geometry and scar/fibrosis pattern. The goal of this project is to improve the parameterization of patient-specific computational models of atypical atrial flutter.